Small Molecule Activators of Pro-apoptotic BAX for Cancer Therapy

ABSTRACT
Resistance to apoptosis is one of the hallmarks of cancer. Cancer cells circumvent cell death through the
mitochondrial apoptosis pathway to ensure tumor growth, maintenance and resistance to current treatments.
The mitochondrial apoptosis pathway is governed by the expression levels and interactions of the BCL-2 family
proteins, which comprise the pro-apoptotic effector proteins BAX and BAK, the anti-apoptotic proteins e.g. BCL-
2, BCL-XL, MCL-1 and the pro-apoptotic BH3-only proteins. Cancer cells most commonly block mitochondrial
apoptosis by upregulating the anti-apoptotic BCL-2 proteins that neutralize BH3-only proteins and activated BAX
and BAK. Therefore, efforts have focused on the development of selective inhibitors of anti-apoptotic BCL-2
proteins to re-activate apoptosis. Inhibitors such as the FDA-approved Venetoclax rely on the function and
availability of BH3-only proteins to activate BAX and BAK. However, in many tumors, BH3-only proteins can be
downregulated, suppressed or deleted, making these tumors insensitive to these inhibitors and limiting their
broader clinical application. We hypothesized that small-molecule direct activation of pro-apoptotic BAX via the
BAX trigger site is an alternative and possibly complementary pharmacological strategy to promote apoptosis in
cancer cells. This approach can promote BAX activation independently of BH3-only proteins and therefore
should have the potential to overcome apoptosis blockade in resistant tumors. Our laboratory recently used
unique structural and molecular insights and medicinal chemistry to develop a potent and selective compound,
termed BAX Trigger Site Activator 1(BTSA1) that promotes BAX activation and induces mitochondrial
dysfunction and apoptosis. Using BTSA1, we provided proof-of-concept for direct BAX activation as a therapeutic
target in Acute Myeloid Leukemia and demonstrated that direct BAX activation is well tolerated in vivo. Here, we
hypothesized to generate BTSA1 analogues with improved potency, oral bioavailability and pharmacokinetics.
Our goal is to evaluate their activity and mechanism of action in diverse cancer models as single agents or
combination treatments and investigate mechanisms of sensitivity and resistance to BAX activation and
apoptosis. Moreover, we aim to identify a clinical candidate BAX activator with favorable cellular,
pharmacological and safety properties. Therefore, we propose the following specific aims: 1) characterize
potency, selectivity, pro-apoptotic activity, in vitro ADME/Tox and pharmacokinetic properties of BTSA1
analogues, 2) determine cellular efficacy and mechanism of action of 2nd generation BTSAs, including BTSA1.2,
alone and in combination treatments using various leukemia and solid tumor cells and investigate determinants
of sensitivity and resistance, 3) determine safety and therapeutic potential of select BTSAs alone or in
combination therapy and investigate novel biomarkers and mechanisms of apoptosis regulation. This proposal
will advance an innovative therapeutic strategy and therapeutics and inform the most suitable context for
targeting BAX activation in cancer.

Public health relevance
NARRATIVE Evasion of apoptosis is a hallmark of cancer development, maintenance and chemoresistance. Pro-apoptotic BAX functions as gateway to apoptosis induction and our previous work has highlighted direct BAX activation as a promising therapeutic strategy. The goal of this proposal is to investigate small-molecule BAX activators in different type of tumors and investigate novel mechanisms and biomarkers that will facilitate the application of BAX activators to cancer patients.